ABCD-USA Consortium: Coordinating Center

PROJECT SUMMARY
Here we request funds to continue work to pursue the following augmented aims that expand the original scope
of the ABCD study:
• Address important questions about the possible roles of gender identity, sexual identity, and sexual health
in modifying important health, mental health, and other outcomes measured in ABCD.
• Enhance the capacity within ABCD to answer important questions about sexual health in adolescents,
particularly about normative trajectories of gender and sexuality.
To accomplish this, the ABCD consortium has made modifications to the design of the study adding, and
sometimes developing, new methods for measuring, in a developmentally sensitive and developmentally
informed manner, the gender identity, sexual identity, and sexual health of participants in the ABCD study.
Ongoing evaluation of the study assessments across multiple domains are needed to ensure that the study
adequately captures risks that may be increased in sexual and gender minority participants.
The supplemental funding has established the Gender Identity and Sexual Health (GISH) workgroup with
membership from the ABCD investigator group, NIH, and CDC. This workgroup functions like other expert
workgroups in ABCD with responsibility for a specific set of interactions with the CC, DAIRC, and other
advisory and oversight groups within and external to the consortium. In the proposal, we describe the CC -
DAIRC-workgroup interactions required to generate, evaluate, integrate, monitor, update, interpret, an d
share all data collected within the ABCD Study. Continued funding is needed for ongoing protocol revision to
improve measurement of gender and sexuality in ABCD, ensuring the validity and youth acceptance of proposed
protocol revisions, and to offset costs to the centers and sites of including these assessments within the current
ABCD study design. This year’s funding includes an equity audit (detailed in the research plan), where
contract SGM scholars from NORC at the University of Chicago, will work with the GISH workgroup to review
the ABCD protocol, gather information from ABCD stakeholders, and prepare a report informing the consortium
of protocol areas that have the potential to be experienced differently by sexual and gender minority participants.
This work is intended to inform future qualitative data collection (focus-groups) from non-ABCD adolescents
(oversampling SGM adolescents) on the GISH measures and other identified protocol elements to improve data
collection methods.

Public health relevance
PROJECT NARRATIVE The original design and scope of the ABCD Study provided only limited information about the impact of developing gender identity and sexual health of youth on their health and mental health outcomes. This project aims to augment the information that the ABCD Study will provide about the normal trajectory of gender and sexual identity, and about any increased risks for more adverse outcomes that may be borne by some gender and sexual minority youth.